Physiology of ClC-K2/b Cl- channel in the collecting duct

Abundant basic and clinical evidence identify a critical role of the augmented epithelial Na+ channel (ENaC)
mediated reabsorption in the collecting duct (CD) principal cells in the pathology of salt-sensitive and Angiotensin
II (Ang II)-dependent hypertension. On the contrary, aldosterone-mediated increases in ENaC activity during
hyperkalemia are necessary to stimulate potassium secretion with no sign of volume retention. Here, we propose
that the unique mosaic structure of the CD, consisting of electrically uncoupled principal and intercalated cells,
is instrumental for separate control of Na+, K+ and Cl- fluxes to determine its transport profile from volume
retention (Na+ and Cl- reabsorption) to Na+/K+ exchange (coupling Na+ reabsorption to K+ secretion). We further
generated strong preliminary evidence supporting essential role of ClC-K2/b channel mediated Cl- flux in
intercalated cells in this process. Using freshly isolated murine CDs, we found that ClC-K2/b activity and
expression is inversely related to dietary Cl- but not K+ intake. Moreover, Ang II exhibits multicomponent
stimulatory effects on ClC-K2/b activity, trafficking and channel abundance in the CD intercalated cells
implicating its important role in ClC-K2/b activation during low Cl- diet and volume depletion. Consistently, mice
lacking Angiotensin type 1 receptors (AT1R) are hypovolemic and have reduced renal ClC-K2/b expression.
Overall, we hypothesize that ClC-K2/b function in intercalated cells is primarily regulated by dietary Cl- intake
likely in an Ang II-dependent manner. This discretional anionic ClC-K2/b-mediated Cl- influx reduces the ENaC-
generated driving force for K+ secretion enabling to tune CD transport profile from Na+/K+ exchange during
hyperkalemia (only aldosterone is elevated) to NaCl reabsorption during hypovolemia (both aldosterone and Ang
II are increased). Concomitant over-stimulation of ENaC and ClC-K2/b shifts the CD operation to NaCl
reabsorptive mode, thereby contributing to the pathology of Ang II-induced hypertension. To address this central
hypothesis, we developed 3 specific aims:
SA1: Examine regulation of ClC-K2/b activity and expression in the CD by dietary cues. Establish the
contribution and supremacy of Ang II and aldosterone in this process.
SA2: Define the mechanism of action and delineate the cellular signaling pathway of Ang II regulation of ClC-
K2/b activity in the CD.
SA3: Establish pathophysiological ramifications of augmented ClC-K2/b activity in the CD in the pathology
of Ang II-dependent hypertension using transgenic mice with targeted channel deletion.
In summary, this proposal seeks to greatly expand our understanding how electrolyte transport in principal
and intercalated cells integrate for proper CD response to dietary and endocrine inputs. Moreover, it also
provides physiologically relevant means to target ClC-K2/b-dependent Cl- reabsorption in the CD as a tool to
fight salt-sensitive and Ang II-dependent hypertension in clinical setting.

Public health relevance
PROJECT NARRATIVE The problem of high blood pressure is particularly important since more than 20% of all Americans suffer from high blood pressure. Appropriate dietary salt handling by the kidneys is pivotal to blood pressure control. In this proposal, we determine new mechanism for independent regulation of salt constituents, namely sodium and chloride, by the distal part in the renal tubule and determine its importance for the pathophysiology of salt- sensitive and angiotensin II-dependent hypertension.